Modeling reductions in harmful alcohol use on HIV transmission and mortality in the era of universal test and treat in Uganda

Abstract
The World Health Organization (WHO) recommends that all people with HIV (PWH) initiate ART and
countries in Sub-Saharan Africa (SSA) have started to roll-out a universal test and treat (UTT) strategy. Recent
trials have shown that expanded treatment does not always result in reduced HIV incidence at the population
level. Questions remain on the role of underlying factors that may reduce the benefits of UTT and drive the HIV
epidemic. According to a recent UNAIDS report, alcohol use is an overlooked factor in the HIV epidemic that
requires greater attention. Alcohol use increases HIV risk through sexual behaviors and reducing uptake and
adherence to ART. Thus, alcohol use may contribute to population level failure to achieve HIV elimination
targets. My proposed research will estimate the long-term, population impact of harmful alcohol use on HIV
transmission and mortality in the UTT era in Uganda. Uganda has one of the highest levels of alcohol use per
capita in SSA and has a generalized HIV epidemic, with a prevalence of 5.7%. The UTT strategy took effect in
Uganda in 2017. However, in 2019, 22% of PWH in Uganda were not on ART and 36% were not virally
suppressed. Uganda has an opportunity address both burdens by reducing harmful alcohol use. My research
will assess the value for money of investing in alcohol use interventions to reduce HIV transmission in the era
of UTT in Uganda. This project will improve understanding of the relationship between harmful alcohol use and
the HIV epidemic through the following aims: 1) Estimate the prevalence of harmful alcohol use and
relationships with receipt of ART and viral load suppression in the era of UTT in Uganda 2) Quantify the
contribution of harmful alcohol use to HIV transmissions and mortality in Uganda during the UTT era, using
infectious disease modeling. 3) Determine the cost-effectiveness of alcohol reduction interventions to prevent
HIV transmission, in Uganda. The candidate, Dr. Adriane Wynn, is well qualified to conduct this research
because of her strong background in quantitative methods and track record of publications and successful
grant writing. Over the 5-year award period, Dr. Wynn will achieve the following career development objectives:
1) Develop expertise in the epidemiology and intersection of alcohol use and HIV and alcohol reduction
interventions in the era of UTT in Sub-Saharan Africa. 2) Gain skills in modeling the population impact of
alcohol use on HIV transmission and disease progression. 3) Acquire expertise in health economic evaluation
of alcohol reduction interventions incorporating HIV transmission prevention benefits. 4) Obtain expertise in the
ethical conduct of research pertaining to alcohol-using populations and those at risk for or living with HIV. 5)
Expand professional development skills in preparation for a successful academic career by further developing
skills in grantsmanship, publication, and scientific collaborations. These aims are in line with the Office of AIDS
Research high priority topics: “Reducing Incidence of HIV/AIDS” and the NIAAA’s Strategic Plan.

Public health relevance
Project Narrative According to a recent UNAIDS report, alcohol use is an overlooked factor in the HIV epidemic that requires greater attention. My proposed research will estimate the long-term, population impact of harmful alcohol use on HIV transmission and mortality, and will assess the value for money of investing in alcohol use interventions to reduce HIV transmission in the UTT era in Uganda. As countries in Sub-Saharan Africa seek to end the HIV epidemic, my research could provide impactful information for policymakers on integrating alcohol and HIV strategies and resource allocation.